KRAS inhibitors prime cancer cells for macrophage-mediated destruction

Project Summary
Approximately 20% of all human cancers contain a mutation in the KRAS oncogene that drives their growth
and metastasis. Novel KRAS inhibitors have recently been developed that disable these growth signals.
Although they help patients live longer, KRAS inhibitors are unlikely to cure patients. For this reason, there is a
need to identify more effective ways to treat KRAS mutant cancers. Based on the success of cancer
immunotherapy, an appealing strategy has been to combine targeted therapies with agents that activate the
immune system to attack. Macrophages are cells of the innate immune system and are often the most
common infiltrating immune cell in solid tumors. The CD47/SIRPa axis is a key regulator of macrophage
activation in the tumor microenvironment and acts as a “don’t eat me” signal. Anti-CD47 antibodies that block
this macrophage immune checkpoint can stimulate macrophage activation against cancer. In this proposal, we
hypothesize that KRAS inhibitors make cancer cells more vulnerable to macrophage-mediated destruction, and
consequently, that KRAS inhibitors will synergize with anti-CD47 antibodies to eliminate KRAS mutant cancers.
Our overall goal is to convert KRAS-targeted therapies into curative therapies by engaging macrophages as
effectors.
To investigate potential synergy between KRAS inhibitors and anti-CD47 antibodies, we have developed a
novel in vitro co-culture assay to evaluate macrophage-mediated destruction of cancer. We will use this assay
to measure synergy between KRAS inhibitors and anti-CD47 antibodies (Aim 1). We will investigate the
mechanism of synergy by assessing how KRAS inhibitors change the expression and function of other
immunoregulatory molecules on the surface of KRAS mutant cancer cells. Next, we will test the combination
therapy in xenograft mouse models of KRAS mutant cancer to evaluate for enhanced anti-tumor immunity in
vivo (Aim 2). Finally, we will investigate the effects of the combination therapy in immunocompetent, syngeneic
tumor models to understand how the combination therapy alters interactions between the innate and adaptive
immune systems. Overall, we propose a novel mechanism to enhance the efficacy of KRAS inhibitors by
merging the fields of immuno-oncology and precision medicine. We expect our findings to provide the rationale
for rapidly translating this combination strategy to the clinic to benefit patients with KRAS mutant cancer.

Public health relevance
Project Narrative Cancer is one of the leading causes of death in the U.S. and worldwide. Many conventional cancer treatments are often ineffective and cause substantial side effects. This study will identify ways to boost the effects of drugs called targeted therapies by combining them with a new type of therapy that activates immune cells to attack and eliminate cancer.